INVESTIGATION ON AN UNKNOWN PROTIST

(Supported in part by NSF OCE 9417097 to B. Basin) As a prelude to physiological experiments, the ultrastructure of bentic foraminifera inhabiting the REDOX discontinuity layer of marine sediments in the Santa Barbara Basin are being investigated for possible clues concerning their adaptations to such a geochemical environment. To date, we have found what appear to be magnetotactic bacteria in one foraminiferal species, and cyanobacterial symbionts in another. Neither of these observations have previously been reported in the literature. By reviewing thick preparations in stereo on the HVEM we hope to gain more knowledge of the bacteria as well as other ultrastructural features of the forms such as peroxisome-E.R. complexes. These structures are lost during routine thin sectioning. We are investigating an unknown organism which epifluor staining has revealed to be an epibiont protist which harbors bacteria on its exterior. Preliminary HVEM results from serial-section examination show that there are 3 separate nuclei in this protist. Further studies of other organelles such as golgi need to be carried out. We also hope to study stereo pairs to understand the contact of the external bacterial with the host. Bernhard, J.M. (Late 1996) Microaerophilic and facultative anaerobic benthic foraminifera: A review of experimental and ultrastructural evidence. Revue de Paliobiologie, 15:261-275. Gupta, S., E. Platon, J.M. Bernard and P. Aharon. (1997) Foraminiferal colonization of hydrocarbon-seep bacterial mats and underlying sediment, Gulf of Mexico slope. J. Foraminiferal Res., (in press)